Contextual and intrapersonal influences on impaired control over drinking

Project Summary for the Administrative Supplement The purpose of this COVID-19 Administrative Supplement (PA-18-591) is to provide the principal investigator of K01AA024160-05, Dr. Julie A. Patock-Peckham, with the appropriate resources that will allow her to recover from COVID-19 disruptions as well as allow her to succeed as an independent investigator capable of conducting R01 funded projects through NIH/NIAAA. COVID-19 halted many aspects of the research and training process that require additional funds to support percent effort for both the staff and the P.I. Dr. Patock- Peckham requires additional support to complete specific aims 3 and 3b of the parent grant. While, Dr. Patock-Peckham is a recognized expert in the study of trait impulsivity and impaired control over drinking using survey methods, she requires additional statistical training in multi-level modeling involving mediational tests as well as training in biomarkers of response to stress and alcohol for her future work. The financial support outlined in this proposal would allow Dr. Patock-Peckham to expand her current statistical skill set and include working with group level drinking data with proper multi-level modeling training advanced enough to handle group level clustered data with mediating mechanism questions. Dr. Patock-Peckham has been fortunate to find a proper multi-level modeling trainer, Dr. Daniel McNeish, at her local university but requires funds for his effort. One of the major goals of the parent K01 grant, specific aim 3 will answer whether cold executive function (EF) via the cued go no go task mediates the impact of a priming dose of alcohol on one's choice to drink beyond recommended limits. Another goal of specific aim 3 of the K01 grant was to answer whether hot (emotional) EF via emotional cued go no go task mediated the impact of the acute stress (TSST) on the decision to continue drinking. Further, one of the major goals of the K01 grant was for Dr. Patock-Peckham to receive appropriate advanced training in multi-level modeling so that she could examine research questions in both solitary and group level drinking situations in the future. This would enable Dr. Patock-Peckham to become one of only a few alcohol self-administration researchers (less than five worldwide) capable of conducting this sort of work independently. Another major goal of the parent K01 training grant was for Dr. Patock-Peckham to receive appropriate training in biomarkers for stress. In particular, Dr. Patock-Peckham will seek additional training regarding cortisol hormones in response to an acute stressor (i.e. the Trier Social Stress Task; TSST). Costs for the cortisol analyses as well as the training components of the original parent K01 training grant have substantially increased since it was proposed. Being able to afford to complete the cortisol analyses and cortisol training will allow Dr. Patock-Peckham to become one of only a handful of researchers knowledgeable with trait measures of stress, experimental manipulations of acute stress (TSST), and of physiological biomarkers of stress. Taking a multiple method approach to stress will greatly strengthen new R01 grant applications regarding the causal links between stress and alcohol consumption.

Public health relevance
Administrative Supplement Narrative Drinking to excess in a social drinking context represents an important component of alcohol dependence, yet little is known about the etiology of impaired control over drinking (IC) within a group context. The current study addresses this gap in the literature by examining the influence of an acute social stressor (Trier Social Stress Task; TSST) on hot and cold executive function mediating mechanisms as well as cortisol stress hormone reactivity on IC. Understanding the conditions under which IC occurs and the mechanisms of influence will facilitate refinement of intervention approaches targeting the unique needs of individuals with IC to overcome alcohol dependence.